Analysis Core

Project Summary/Abstract – Analysis Core
The Deep South RCMAR’s primary objective is to increase both the number and diversity of investigators with
the capacity to conduct independent research related to minority aging and health disparities. The research
focus of the Deep South RCMAR is on reducing health disparities between non-Hispanic Black/African
American (B/AA) and non-Hispanic White older adults in the Deep South, the region of the country where the
majority of older B/AAs live, and where health disparities have been particularly persistent. The Analysis Core
(AnC) will support the vision and activities of the Deep South RCMAR by providing mentoring and training to
Scientists in the areas of methods, measurement, assessment of social determinants of health (SDOH), and
secondary data analysis as it relates to health disparities and minority aging. The AnC will achieve this goal by
leveraging existing expertise, data resources, and infrastructure at our four partnering institutions (University of
Alabama at Birmingham, Morehouse School of Medicine, Tuskegee University, and The University of
Alabama). We will also promote the recruitment of diverse samples and the importance of diversity, equity,
inclusion, and accessibility (DEIA) in the workplace and research. The AnC aims consist of a three-fold
strategy. First, we will collaborate with the Research Education Component (REC) and the Community Liaison
and Recruitment Core (CLRC) to mentor and train Scientists in methods and measurement techniques related
to the study of health disparities within older B/AA and White individuals in the Deep South. This will include: a)
conducting training in methods, measurement, examining SDOH, and reliably assessing psychosocial aspects
of health disparities/minority aging; and b) facilitating linkage of Scientists with methodological, biostatistical,
and analytical resources available within the Deep South RCMAR and affiliated centers. Second, in
collaboration with the REC and the CLRC, we will mentor and train Scientists to conduct secondary data
analyses using psychosocial, economic, clinical, and genetic data, with the goal of informing the development
and evaluation of interventions to address health disparities among older adults in the Deep South. This will
include: a) conducting training in secondary data analysis with a focus on data with Deep South RCMAR
expertise; b) facilitating mentoring of Scientists in the analysis of secondary data by establishing workgroups
comprised of Deep South RCMAR faculty and Scientists with expertise in datasets relevant to minority aging
and health disparities; and c) funding a secondary analysis award each year to increase the productivity of
RCMAR Scientists. Finally, we will (a) collaborate with the RCMAR Coordinating Center in the dissemination
of culturally sensitive measures and analysis techniques relevant to minority aging and (b) promote DEIA in the
workplace and research via local and national trainings for RCMAR faculty and Scientists.